Regulation of Cell Fate and Treatment Response in WNT Medulloblastoma

ABSTRACT
We have identified mutations in the X-linked, RNA helicase DDX3X as the second most frequent mutation in
medulloblastoma (MB). We now show that DDX3X: (i) orchestrates normal hindbrain patterning and
development; (ii) suppresses the initiation of Wnt and Shh MB; (iii) restricts the susceptibility of specific NPCs to
generate these tumors; and (iv) serves as a `rheostat' in the stress response, regulating global patterns of gene
transcription and translation and live-die `decisions. Our studies also helped explain why WNT-MBs are
eminently curable. We showed that paracrine signals driven by mutant CTNNB1 in WNT-MB disrupts the blood
brain barrier (BBB), permitting the accumulation of high levels of intra-tumoral chemotherapy and a robust
therapeutic response. Here, we will continue our focus on WNT-MB to address three new Specific Aims that will:
determine how DDX3X regulates cell fate decisions in the normal and malignant hindbrain; generate novel
immunotherapies of WNT MB; and translate new treatments of WNT MB to clinical trial.

Public health relevance
PROJECT NARRATIVE Medulloblastoma (MB) comprises four distinct subtypes with different cellular and molecular origins, and different clinical outcomes. We will investigate how DDX3X, the second most frequently mutated MB gene affecting three MB subtypes, patterns the hindbrain and suppresses MB. We will identify novel effective therapeutic approaches to minimize debilitating long-term toxicities for patients with the WNT-MB subtype.